Fluoride-Mediated Desilylative Radiosynthesis of 11C-Labeled PET Tracers

PROJECT SUMMARY
Positron emission tomography (PET) is a highly sensitive molecular imaging technique used for studying
biological systems in vivo, as well as for clinical diagnostic purposes. The ubiquitous presence of carbon in
most organic molecules makes carbon-11 an attractive and important positron-emitting radionuclide for
labeling molecules of biological interest. Because 11C has the same chemical properties as 12C, 11C is
especially useful for rapid exploration of molecules with well-characterized biological and pharmacological
properties (i.e., metabolism, receptor binding affinity, enzyme substrate affinity, etc.). In addition, the short half-
life of 11C (20.4 min) facilitates the possibility of multiple studies on the same subject in a single day due to the
low radiation dose and absence of overlapping activity between scans. This opens up the possibility for
longitudinal studies and studies involving an intervention, making it particularly desirable for basic and clinical
research investigations. The lack of methods to introduce and incorperate11C into organic molecules
conveniently and quickly limits the utility of this radioisotope. So far, the main criteria for successful synthesis
of 11C-lableled PET tracers is a rapid, robust and practical radiolabeling method that yields the desired tracer
with high radiochemical purity, chemical purity, and/or high molar activity. This is especially a challenge when
[11C]CO2 is used as radiosynthon for synthesis of desired PET tracers. In this proposal, we will develop
methods to address this issue. Our three Specific Aims are: 1). develop a fluoride-mediated desilylation
(FMDS) 11C-labeling methodology to directly incorporate [11C]CO2 into skeleton of molecules with diversified
structures. It is expected that this novel approach will provide facile and rapid access to 11C-labeled
compounds with carbon-11 attached at various hybridized carbons (sp, sp 2 and sp3) with broad functional
group tolerance; 2). Further extend FMDS 11C-labeling methodology to other accessible 11C-electrophiles (such
as [11C]CH3I/[11C]CH3OTf). Our goal is to develop a new 11C-methylation method, which can serve as a
complementary approach for synthesis of various 11C-labeled PET tracers; 3). Utilize FMDS 11C-labeling to
solve some long-standing problems in radiotracer chemistry research by developing facile and practical
labeling methods for radiotracers of high clinical interest where regular production is very difficult using
currently reported methods, such as [11C]pyruvic acid, [11C]succinic acid, [11C]PHNO, [11C]vorozole. This newly
developed FMDS 11C-labeling methodology may lead a brand new direction in radiotracer chemistry and open
multiple avenues for developing novel and practical radiolabeling methodologies.

Public health relevance
PROJECT NARRATIVE The goal of this research is to develop a fluoride-mediated desilylation (FMDS) 11C-labeling methodology, and use this novel approach for facilitating 11C-labeled radiotracer development to synthesize novel, currently radiochemically inaccessible or difficult to access PET agents.